Administrative Core

ABSTRACT CORE A
The Geroscience hypothesis is based on the observation that healthspan decline toward the end of life often
presents with a single age-related illness that is followed by the rapid accumulation of age-related complications
over a relatively short period of time. According to this hypothesis, treating any one of these conditions without
treating the fundamental biology of aging will only result in its substitution by another. Although pneumonia
causes excess mortality in older people, most elderly patients with access to modern health care survive
However, in the year after hospital discharge these older pneumonia survivors have an increased risk of
developing age-related disorders including persistent lung injury, skeletal muscle dysfunction leading to
immobility, myocardial infarction, chronic kidney disease, dementia and cognitive impairment. As such,
pneumonia is a gateway for the compounding morbidity that limits healthspan at the end of life. In the first cycle
of this award, we used unbiased transcriptomic and proteomic approaches to suggest age-related resilience can
be restored by partial inhibition of mitochondrial metabolism through the integrated stress response via Activating
Transcription Factor 4 (ATF4). Core A will assist the PPG investigators as they test this central hypothesis of
this PPG through a highly integrated and innovative set of experiments by focusing on five Specific Aims:
Specific Aim 1. To support communication between the Project Investigators, the Core Leaders, Collaborating
investigators, and the Internal and External Advisory Committee members.
Specific Aim 2. To provide a structure for the sharing of materials and dissemination of information between the
Project Investigators, Core Leaders and their Collaborators.
Specific Aim 3. To provide financial and regulatory oversight to the Project and Core Leaders and coordinate
their interactions with Institutional Core Services.
Specific Aim 4. To disseminate the discoveries made by the program project investigators through publications,
presentations and the sharing of reagents and techniques to other institutions and other investigators.
Specific Aim 5. To foster an environment of collaborative interdisciplinary research and mentoring of
students, post-doctoral fellows and investigators.

Public health relevance
PROJECT NARRATIVE It is not required per instructions stated on the Funding Opportunity Announcement PAR-18-297, Section IV. Application and Submission Information, Project, Research & Related Other Project Information (Core), “Project Narrative: Do not complete”.